Comprehensive Assessment of Right Ventricular and Pulmonary Vascular Function via CT Imaging in Heart Failure Patients

Project Summary
Parent Award: Mechanical circulatory support is required by a large percentage of patients who
undergo heart transplant and serves as a destination therapy for end-stage heart failure patients who are
ineligible for transplant. However, clinicians are currently unable to predict the up to 40% of patients who
develop right heart failure after receiving left ventricular assist devices. This project aims to use CT to obtain
load-independent measures of ventricular function and ventricular-arterial coupling to improve
prediction of right heart function and failure in patients receiving left ventricular assist devices.
Supplement: This supplement extends the utility of the CT imaging proposed in the parent award and
supports the training and development of a bioengineering graduate student. Recent work has enabled robust
mapping of regional dysfunction via new CT-based quantitative metrics. Specifically, we have combined
regional strain measured via CT (RSCT) with RV pressure waveforms to estimate regional myocardial work
(MW) as the area of the pressure-strain loop (MWCT). However, the utility of MWCT as an indicator of RV
dysfunction in TOF patients has not been established. Therefore, we propose to determine whether the
amount of myocardium with impaired MWCT better predicts functional impairment than RSCT and volume
measurements. This work not only aims to improve prognostic evaluation but could also yield mechanistic
insights into why the RV is at risk of failing. Importantly, this work seamlessly builds on the data collection and
analysis efforts already underway as part of the parent award.
In addition to this new research direction, the supplement outlines tailored training for a promising PhD
student already being mentored by the principal investigator. Together, they have developed a set of training
activities which will enable her to thrive at the interface of cardiology, radiology, and bioengineering.
Specifically, she has fostered a collaboration with a cardiologist who will provide opportunities for her to
shadow clinical care of patients and take part in multidisciplinary patient discussions. In addition, she has
identified conferences, journals, and supplemental coursework which will provide her the networking,
publication, and training experiences she needs to continue her work in this translational field.

Public health relevance
Project Narrative In the parent award, we aim to use CT imaging to evaluate whether abnormal right ventricular-pulmonary arterial coupling represents a sensitive and specific parameter defining patients whose right ventricle will fail following insertion of a left ventricular assist device. Recently, our group has developed new imaging metrics which can evaluate regional RV mechanics in these patients and the PI has been recognized for excellence in mentorship. In this supplement, we request support for a current graduate student to pursue this new CT- based technique and further their graduate training.